Coordinated cellular heterogeneity in the thick ascending limb and distal tubule

In this proposal, we will define cell states in the kidney, and specifically along the thick ascending limb, distal
convoluted tubule, and connecting tubule in health, and during stress. In preliminary work, we have used an
technique called INTACT to enrich specific cell types, allowing us to study their transcriptome in unparalleled
detail. We have combined this approach with immunohistochemistry, allowing us to find new cell types in these
tubule segments. We recently used this approach in a publication defining the distal convoluted tubule Here,
we will use new mouse lines that allow us to enrich connecting tubules to test how potassium stress and
diuretic drugs alter cell state, leading to both homeostatic adaptation and to dysfunction. We will then examine
thick ascending limb cells, where our preliminary data suggest the presence of two previously unrecognized
cell types. One of these generates a transepithelial voltage and mediates salt reabsorption. The other is
electrically neutral, but mediates the reabsorption of calcium and magnesium. We will then test whether water
stress and calcium stress activate these cell types selectively. To achieve this, we have planned the following
Specific Aims:
Aim 1: Define the role of cell types and states in DCT and CNT function
Characterize cell types along DCT and CNT
Determine how dietary K+ intake alters cell state to modulate Ca2+ excretion
Determine how diuretic drugs alter cell state to modulate Mg2+ and Ca2+ excretion
Aim 2: Define the role of cell types and states in TAL function
Characterize TALa and TALb cells and develop a new physiological model
Determine how water stress and arginine vasopressin affect TALa cell states and function
Determine how calcium stress affects TALb cell states and function

Public health relevance
Project Narrative The kidney comprises many different cell types, oriented along tubules. The various cell types along these tubules are crucial for the body to retain solutes such as sodium and calcium. We will study how kidney stress alters these cell types, and how their dysfunction can cause human disease.